Rescue of synaptic pathology in an Alzheimer's mouse model by enhancing MET receptor tyrosine kinase signaling

Project Summary/Abstract
Alzheimer's disease (AD) imposes an overwhelming socioeconomic burden on our society. Key pathological
hallmarks of the AD brain are degenerating cortical neurons with neurofibrillary tangles, Tau, and Aβ. At the
cellular and functional level, AD is characterized by impaired synaptic function and synapse loss across many
forebrain regions, and is manifested as disrupted synaptic plasticity, learning, memory, and general intellect.
Mouse models recapitulating certain aspects of AD pathology have been extensively employed to study
mechanisms of neural degeneration and assess efficacy of therapeutic interventions. Recent literature
revealed that MET receptor tyrosine kinase, heavily expressed in the excitatory neurons at early
developmental stages yet functions as a synaptic signaling protein in the adult brain, is reduced in AD brain.
Activation of MET initiates a pleiotropic signaling that exerts neurotrophic and neuroprotective effects in
multiple neurodegenerative mouse models. However, how MET signaling affects AD pathogenesis has not
been investigated. The goal of this proposal is to test whether synaptic pathology in an AD mouse model can
be rescued by enhanced MET-mediated signaling. Recent work from this research team showed that MET
signaling in the developing cortical circuits promotes dendritic spine formation and synaptogenesis, refines
circuit connectivity, and controls the timing of excitatory synapse maturation. More intriguingly, preliminary
data using unique ‘humanized’ hMET conditional knockin (cKI) mice created in the PI’s laboratory revealed
altered transcriptome profiles, increased hippocampal long term potentiation (LTP) and enhanced learning and
memory. In addition, elevated MET signaling in adult hippocampal CA1 neurons resulted in enhanced synaptic
transmission and increased spine density indicative of de novo synaptogenesis. These exciting results have
led to the hypothesis that enhancing MET-mediated pleiotropic signaling prior to neurodegeneration in an
amyloid AD mouse model (5xFAD) may rescue the disrupted molecular pathways, reduce pathological
synapse losses, and alleviate the cognitive decline. To address this hypothesis, two specific aims are
proposed to test whether hMET-cKI signaling alleviates molecular and pathological changes (Aim 1) and
mitigates the synaptic loss and cognitive decline (Aim 2) in the 5xFAD mouse model. Impact: The
hypothesized beneficial effects of hMET signaling highlight the potential of an endogenous pleiotropic
developmental molecular signaling as a novel candidate for neurotrophic therapy in AD.

Public health relevance
PROJECT NARRATIVE The proposal is relevant to public health because Alzheimer’s disease (AD) is the most prevalent form of dementia that is characterized by the progressive loss of functional synapse and cognitive decline. MET receptor tyrosine kinase, a pleiotropic signaling program known to be neurotrophic and neuroprotective, is decreased in AD brain. The study will test the hypothesis that enhancing MET signaling in mice through a genetic knockin approach alleviates AD related pathology and loss of synaptic function and plasticity, which could reveal a novel endogenous molecular signaling that may be targeted for AD therapeutics.